IUSM Alzheimer's Disease Drug Discovery Center

PROJECT SUMMARY/ABSTRACT
Alzheimer’s disease (AD) is a fatal neurodegenerative condition characterized by cognitive decline, β-amyloid
(Aβ) plaques, and tau-containing neurofibrillary tangles (NFTs). Recent human genetic evidence supports an
important role for microglia and neuroinflammation in the etiology of AD. Microglia are the resident immune cells
in brain that maintain neuronal health and proper immunomodulation of neighboring glial cells. Microglia clear
neurotoxins, Aβ oligomers, and Aβ plaques, and thereby mitigate an inflammatory microenvironment that is toxic
to neurons. Genetic evidence suggests that lower expression of the cell surface microglial immune receptor
known as Triggering receptor expressed on myeloid cells-2 (TREM2) and inactivating variants (e.g. R47H) of
this receptor are correlated with an increased risk of developing of AD. Conversely, enhanced signaling
downstream from TREM2 via the Phospholipase C gamma 2 (PLCγ2) P522R variant is protective. This genetic
evidence suggests that dampened microglial activity increases risk of neurodegeneration while activated
microglia are protective. Src homology 2 domain containing inositol polyphosphate 5-phosphatase 1 (SHIP1) is
a member of the inositol polyphosphate-5-phosphatase (INPP5D) family, which has also been identified as a
risk gene for AD. INPP5D encodes SHIP1, which is a phosphatidylinositol phosphatase that plays a key role
regulating pathways downstream from TREM2 by binding immunoreceptor tyrosine-based inhibition motifs
(ITIMs), competing with kinases, and modulating phosphatidylinositol-dependent signaling. We hypothesize that
knockdown of INPP5D/SHIP1 will increase signaling downstream from TREM2 thus increasing microglial
protective functions, which will result in a reduced rate of disease progression and cognitive decline in AD
patients. To test this hypothesis, we will design and synthesize oligonucleotides for the efficient siRNA
knockdown of INPP5D (Aim 1). We will develop a screening assay for the selection of oligonucleotides with
optimal knockdown efficiency (Aim 2). Importantly, these oligonucleotides will be modified for efficient tissue
distribution and knockdown efficiency in brain, which will allow the investigation of INPP5D silencing on microglial
activity and related immunological responses in the 5xFAD murine model of AD (Aim 3). Our robust
methodologies aim to elucidate the mechanistic impacts of SHIP1 on neuroinflammation, synaptic integrity, and
broader neuropathological sequela associated with AD. Collectively, these studies will support the translation of
a therapeutic siRNA into the clinic that will reduce neuroinflammation, amyloid burden, and improve cognition,
thus advancing the NIH/NIA mission to develop novel therapies for AD.

Public health relevance
PROJECT NARRATIVE Although the amyloid hypothesis of Alzheimer's disease (AD) has guided drug discovery research for 30 years, more recent human genetic evidence has identified an important role for microglia in neuronal health and the evidence suggests that dampened activity of these important immune cells in brain increases the risk of neurodegeneration while activated microglia are protective. The objective of this proposal is to design and optimize oligonucleotides that can effectively suppress the expression of INPP5D, a gene responsible for encoding SHIP1, an enzyme known to impede microglia activation. Our hypothesis is that knockdown of INPP5D/SHIP1 early in disease will increase the protective functions of microglia and result in a reduced rate of disease progression and cognitive decline in AD patients.